Administrative Core

Modified Project Summary/Abstract Section

This P50 Center entitled Partnering for Engagement: An Academic and Community Alliance to Eliminate Differences throughout the Fibroid Experience (PEACE) is a national partnership created to improve health throughout the uterine fibroid experience. This innovative and visionary center will be supported by an Administrative Core that will provide overall support for the management and coordination of PEACE activities across its three projects and its Community Partnerships, Education, and Outreach Core (CPEOC) which hosts the Center’s Community Stakeholder Advisory Board (CAB). The Administrative Core will monitor progress and ensure that all component plans are successfully implemented per proposed timelines and will promote PEACE at local, state, and national levels. The Administrative Core will also organize and promote an annual PEACE Symposia, which will be a national meeting to celebrate fibroid-related science, patient advocacy, and progress. The following objectives of the Administrative Core are central to meeting PEACE’s goals: 1) provide a focal point for administration and coordination between sites (University of Michigan, Henry Ford Health, Harvard, Boston University, University of California-Irvine), projects, committees, and boards to foster efficiency and consistency; 2) ensure completion of all compliance activities including the institutional review board (IRB) activities, reports to the sponsor, and budgetary reports; 3) administer the Pilot Grant Funding program; and 4) administer, support, and track dissemination activities including town halls, open houses, presentations, abstracts, and manuscript submissions. The Administrative Core will be responsible for coordinating the activities of the multiple institutions involved in this collaborative and ensuring that component plans are implemented to fulfill the Center’s goals in a timely fashion. It will support the organizational and governance structure of PEACE and will manage and support the entire range of proposed Center activities including ensuring that community partners and organizations are compensated in a timely fashion, and that Biostatistical consultation is readily available. The Administrative Core will be responsible for administering the PEACE Pilot Grant Program including ensuring a national applicant pool and organizing an objective process for selection of awardees. The Administrative Core will financially manage the pilot grant awards and will facilitate multidisciplinary collaboration, support, and mentoring of Early Stage Investigators. The Administrative Core will ensure the dissemination of PEACE work and findings to a broad constituency—from community organizations to scientists to clinicians to patients. It will facilitate and track document development, manuscript submissions, development of a public website, and organization of community-based dissemination events. To promote the work of PEACE, the Administrative Core will also organize an Annual Symposium that will feature an invited guest speaker, presentations from pilot grant awardees, and a poster session. In summary, the Administrative Core represents an integral component needed for the success of this collaborative, multidisciplinary, multi-institutional, and innovative research program.